A National Glycoscience Resource - CCRC Service and Training

PROJECT SUMMARY
The goal of this proposal is to create a National Resource in Glycoscience that will offer service and hands-
on training for compositional analysis and detailed structural characterization of all classes of
glycoconjugates, including glycoproteins, polysaccharides, and glycolipids, to the greater scientific
community. The Complex Carbohydrate Research Center (CCRC) at the University of Georgia has been
home to two NIH/NIGMS federally funded resource centers: the National Center for Biomedical Glycomics
(5P41GM103490), where new technologies in mass spectrometry and transcriptome analysis have been
developed to investigate glycomics and glycoproteomics of stem and differentiated cell types; and the Research
Resource for Integrated Glycotechnology (5P41GM103390), in which mass spectrometry, NMR, molecular
modeling, chemical synthesis and cell based assays have been used to investigate the molecular basis of
protein-carbohydrate interactions. The CCRC service facility has offered a variety of complementary services
using technologies developed by both research resources that are now mature and completely translatable to
investigating the glycomes and glycoproteomes of any tissue or cell type. Since the NIGMS Research Resources
have recently been sunsetted, we propose to combine the “high demand” services from each resource and
create a “National Glycoscience Resource”-CCRC Service and Training (GlyCore) that will enable us to continue
to offer and enhance our cutting edge services in glycoscience, hands-on training courses and workshops and
to make them easily accessible to the biomedical science community. GlyCore will offer a comprehensive list of
services, including isolation and purification, as well as NMR and MS characterization of all glycoconjugates that
are grouped into several categories and are integrated together to help solve particular problems in glycoscience.
In order to better make our technologies available to outside investigators, we will also continue to offer four well-
received and well-established hands-on training courses in glycoscience. Our experience has demonstrated that
the one-on-one format of our training is extremely effective in achieving acceptance of tools in glycoscience. We
have a combination of state-of-the-art NMR and MS instruments and well-trained scientists with particular
expertise and track record for service and training in carbohydrate structural analysis. We have fully implemented
and well-developed protocols for sample receipt, sample handling, sample tracking, storage, data archiving, and
reporting that provide our users with security and analytic outputs of uniform quality. The number of research
groups that have been impacted by our service and training activities spans the whole country and extend
globally. We have built an easily accessible “go-to” service and training facility through extensive outreach
activities, including our Glyco-booth at meetings, seminars, and workshops at conferences, and building close
relationships with universities, scientific non-profit organizations, and industries.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to create a National Resource in Glycoscience that will offer service and hands- on training for compositional analysis and detailed structural characterization of all classes of complex carbohydrates, including glycoproteins, polysaccharides, and glycolipids to the greater scientific community. We propose to combine a complimentary array of our existing high-demand services and create a “National Glycoscience Resource”-CCRC Service and Training (GlyCore) that will enable us to continue to offer and enhance our cutting edge services in glycoscience, hands-on training courses and workshops and to make them easily accessible to the biomedical science community. We will continue to offer four well-received and well- established hands-on training courses in glycoscience, and have a robust infrastructure support with well- developed protocols for sample receipt, sample handling, sample tracking, storage, data archiving, and reporting.